Experimental Therapeutics

PROJECT SUMMARY/ABSTRACT
Research in the Experimental Therapeutics (ET) program focuses on identification, development and testing of
new cancer therapeutics. This is accomplished through three overlapping specific aims centered on 1)
identifying potential targets and discovering therapeutics leads, 2) conducting preclinical evaluation of
promising new therapeutic approaches, and 3) evaluating innovative and promising agents, combinations, and
approaches to monitoring response in clinical trials. ET investigators are highly collaborative. Key scientific
achievements of ET investigators over the prior funding period include identification of novel therapeutic
targets in endometrial cancer and myeloma, nanoparticle based drug development, cancer immunotherapy
based on toll-like receptor (TLR9) agonists, use of pharmacologic ascorbate to enhance the efficacy and
reduce the toxicity of both chemotherapy and radiation therapy (in collaboration with the FRMI Program), and
expansion of investigator-initiated and Phase I capabilities including trials of intralesional therapy. There are 28
full and 16 associate members of ET including laboratory-based, translational and clinical investigators
spanning 13 departments across five colleges. Annual total peer-reviewed cancer direct costs in the most
recent budget year was $2.7 million ($1.9 million from the NCI). Additional funding included $3.8 million for
non-peer-reviewed research projects. ET members are highly collaborative having authored or co-authored
291 cancer-related peer-reviewed publications in the past five years, with 24% (n= 69) intraprogrammatic, 43%
(n= 124) interprogrammatic, and 42% (n= 123) interinstitutional publications. Twenty-nine manuscripts
appeared in high impact journals (Impact Factor ≥10).

Public health relevance
PROJECT NARRATIVE Not applicable